Administrative Core

Administrative Core Abstract
The Center for Multiparametric Imaging of Tumor Immune Microenvironments (C-MITIE) Administrative and
Coordination Core (ACC) will facilitate the work of C-MITIE and maximize its impact. The C-MITIE ACC will be
led by MPIs Paolo Provenzano and Kevin Eliceiri and RTB PI David Odde. Staff Program Manager Bo Connelly
will facilitate the work of the ACC.
The ACC will facilitate efficient and effective leadership of this U54 through quarterly Steering Committee
meetings, participation in, and support of, annual CCBIR meetings and other network events, and annual
External Advisory Panel evaluation of C-MITIE activities.
Developing a robust, iterative exchange of technological innovation and biological insight among the research
test beds and tech unit will be crucial to the success of this center. Building from the strong foundation of
collaboration and friendship among the center leadership, the ACC will develop multiple processes and programs
to facilitate this iterative exchange.
C-MITIE acknowledges that systemic bias is pervasive in our society and recognizes that proactive action is
necessary to cultivate an inclusive center environment diverse in life experience, racial, gender, and cultural
backgrounds. In particular, C-MITIE acknowledges that including the perspective of cancer survivors into the C-
MITIE environment will yield a richer center experience for all centered on the ultimate goal of improving clinical
outcomes for cancer patients. C-MITIE pledges to invest in diversity, equity, and inclusion.